Tobacco-based Sustainable Squalene for Novel Vaccine Adjuvant Emulsions

Project Summary/Abstract
In this grant application, SynShark (SBA Certified Small Business), in collaboration with North Carolina State University,
will demonstrate a new plant source for pharmaceutical grade squalene as a natural adjuvant. The team will utilize novel
plant-engineering routes to stabilize squalene yields in tobacco, and discover methods to manufacture and isolate the
molecule for rapid pandemic response. This research matches the interests of the National Institute of Allergy and
Infectious Diseases (NIAID) with three of its divisions: Division of Aids (DAIDS), Division of Allergy, Immunology and
Transplantation (DAIT) and Division of Microbiology and Infectious Diseases (DMID). Specific branches and programs
under these divisions with relevant statements of needs are: (i) the Vaccine Research Program (DAIDS), (ii) Basic
Immunology Branch (DAIT), (iii) SBIR Adjuvant Research Program – Bacteriology and Mycology Branch (DMID).
The ultimate goal of this activity is the successful commercialization and public benefit of a rapidly derived natural
adjuvant based on plant squalene which is completely biocompatible. Adjuvants have a key role in promotion of vaccine
efficacy through eliciting a stronger immune response and reducing the volumetric need of active ingredient. By all
accounts, evidence was available that SARS-CoV-1 immunity relied on T-cell activation and that vaccines should account
for that. Synthetic adjuvants being used by the current regulated SARS-CoV-1 vaccines are not simulating a strong T-cell
response, while natural squalene known to enhance the magnitude of the T-cell response. But pharmaceutical squalene
is sourced from shark ‘livering’, conveying: 1) the risk of associated pollutants and pathogens, and 2) public resistance. On
the other hand, the other natural adjuvant Quillaja Saponaria oil, costs it’s manufacture Fujifilm Diosynth (in the Novavax
SARS-CoV-1 vaccine) more than $100,000 per kilogram. This has led to Fujifilm Diosynth’s support of this application.
Through terpenoid metabolic engineering, SynShark has already managed to successfully shift the fundamental
carbon allocation pathways within tobacco allowing for increased accumulation of the triterpene squalene. The Phase I
tasks being introduced are directly related to the commercialization plan to deliver to the market a non-animal sourced
natural adjuvant which is grown indoors through proven tobacco pharmaceutical techniques. The Phase I period is
planned to take this innovative and disruptive terpene sourcing technology to fruition by enabling the application of
SynShark’s research advancements in molecular genetics. During Phase I, the tobacco plant will be engineered to study
the feasibility of squalene production directly on the leaf surface by placing the constructs under trichome-specific
promoters, thereby stabilizing yield in a manner best suited for controlled indoor growing. In the Phase II period, SynShark,
through committed collaborators, will establish scalability of manufacturing and purification under US Food and Drug
Administration guidelines.

Public health relevance
Project Narrative In this grant application, SynShark LLC, in collaboration with North Carolina State University’s Crop & Soil Sciences Department, the Plants for Human Health Institute and the Biomanufacturing Training and Education Center, will demonstrate a new plant source for pharmaceutical grade squalene as a natural adjuvant. The ultimate goal of this activity is the successful commercialization and life-changing public benefit of a rapidly derived natural vaccine adjuvant based on this molecule which is completely biocompatible. The team will utilize novel plant-engineering routes first developed under the Department of Energy’s ARPA-E program to stabilize squalene yields in tobacco, and discover methods to manufacture and isolate the molecule for rapid response.